Cancer Immunology Training Program

PROJECT SUMMARY
Interest in cancer immunology has never been more intense. Breakthrough observations with inhibitory receptor
blockade, combined with ground breaking advances in the use of chimeric antigen receptor (CAR)-modified T
cell adoptive therapies have highlighted the critical need to further basic and translation research in cancer
immunology. While the pipeline of potential immunotherapeutic targets is growing, the pipeline of future cancer
immunologists is limited, in part due to significant demand in industry and academia. There is a critical need for
training programs that optimally prepare the next generation of cancer immunologists. Surprisingly, our Cancer
Immunology Training Program (CITP) at the University of Pittsburgh School of Medicine (UPSOM) is one of only
six NCI-supported T32s nationwide that focus entirely on cancer immunology. This makes our program
unique and essential. CITP, which has 5 pre- and 3 post-doctoral slots, is in its 20th year and we are seeking
support for the next five years. The goals of the CITP are to provide graduate students, fellows and physician
scientists with courses, research projects, exceptional environment and resources, and highly-qualified mentors
that will allow them to: (1) make a significant contribution to one of five areas of research focus covered by this
training program: (a) Inhibitory Mechanisms in the Tumor Microenvironment (TME), (b) Adaptive Immunity and
Cellular Interactions within the TME, (c) Innate, Environmental and Metabolic Modulation, (d) Promoting Immune
Responses to Tumors: Cell-Based Therapies & Vaccines, and (e) Systems Cancer Immunology; (2) gain a clear
understanding of the cellular and molecular mechanisms relevant to cancer immunology; (3) obtain a practical
understanding of the immunology of human cancer; (4) gain a clear conceptual understanding of all areas that
impact cancer immunology; and (5) develop critical career skills and managerial ability. Building thoughtfully on
what is a proven training program, we have made several enhancements, such as increasing the cancer
immunology-focus of our faculty (25 total). UPSOM and HCC have and continue to make an unprecedented
investment in cancer immunology. The training program exploits particular strengths at UPSOM, including an
exceptional NCI Comprehensive Cancer Center, a strong immuno-centric translational research base, an
outstanding Immunology Department that underpins strong basic research, and our graduate research program
(PMI). UPSOM has implemented effective programs to ensure outstanding training, with emphasis on increasing
the recruitment and retention of women and URMs. Our applicant pool is exceptional due to the success of our
PMI and MSTP graduate programs, highly sought-after clinical fellowships, and outstanding mentor pool. Over
the last 5 years, CITP has enrolled 24 trainees (Pre – 15; Post – 9), of which 13 were women (54%) and 3 were
URM (12.5%). Lastly, our trainees have been extremely successful in obtaining extramural/competitive
fellowships (14 total [58%]: F99/K00 [1], F32 [3], F31 [4], F30 [3], Damon-Runyon [1], St. Baldrick's [1],
Hartwell [1]). We are excited and eager to train the next generation of cancer immunologists.

Public health relevance
PROJECT NARRATIVE Standard strategies for cancer treatment can have substantial systemic toxicity and while they might provide some short-term efficacy, they are rarely curative in all patients - thus, there is a critical need for new treatments with durable responses and better approaches to prevention. Cancer immunotherapy has made major breakthroughs in the last decade and is likely to have a greater impact in the future. Our Cancer Immunology Training Program (CITP) seeks to train the spectrum of basic to applied and predoctoral to postdoctoral clinical fellows and young scientists to carry out the next generation of cutting-edge research, within the ideally suited, dynamic environment of the University of Pittsburgh School of Medicine and the UPMC Hillman Cancer Center.